LiquidCell EM System with Temperature Control for Biological Imaging

DESCRIPTION (provided by applicant): One of the most challenging, yet highly rewarding tasks in biological research is to visualize with high spatial resolution the structure of molecula machines and their interactions in cellular function under physiological conditions, such as in 37 °C aqueous environment. This proposed LiquidCell EM system with precise temperature control enables direct imaging of many dynamic biological processes in truly native environments with ultra high resolution using transmission electron microscopy. In this proposal, we will fabricate the self-contained liquid cells with ultra-thin viewing windows. Precise temperature control of 37+/-0.1 °C will be achieved through microfluidic device fabrication. Test experiments of imaging individual proteins, protein assembly and live cell functions will be performed to optimize the system for in vivo biological imaging under physiological conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE: LiquidCell EM system with temperature control opens the opportunity for high resolution imaging of biological functionalities under physiological conditions, such as in 37 °C aqueous environment. If successful, this proposal will develop LiquidCell EM systems capable to visualize individual proteins, protein assembly and live cell functions in truly native environment. This novel microscopy technique will be significant for investigations of molecular processes in many fields of biomedical research, including cancer therapy, virology, neuroscience, and cell biology.